IDENTIFICATION OF REGULATORY ELEMENTS THAT MODULATE GLOBIN GENE EXPRESSION

Globin genes exhibit tissue, developmental and maturational specificity. It is our purpose to understand the molecular basis of globin gene regulation. Our efforts have focused on the beta-globin gene cluster that contains the epsilon, gamma and beta genes expressed during the embryonic, fetal and adult developmental periods, respectively. These genes are encompassed within a 60 kb segment of DNA on human chromosome 11. Within this cluster are several cis-acting regulatory elements that interact with trans-acting factors (proteins) to modulate globin gene expression. The locus control region (LCR) located upstream from the cluster contains four regulatory elements (5'HS1-4). Other regulatory elements are contained within the individual gene promoters and enhancers are located downstream from the gamma and beta globin genes. An enhancer within 5'HS-2 interacts with an erythroid specific nuclear protein, NF-E2, to maximize hemoglobin synthesis during erythroid maturation. We have purified one component of NF-E2 from human erythroleukemia cells; this 45Kd peptide co-purifies with the enhancer binding activity but in pure form does not bind to the HS-2 enhancer suggesting the existence of a second subunit. Interaction of the HS-2 enhancer with the gamma promoter when in competition with the beta promoter appears to involve a protein that binds to the sequences between - 35 and -53 upstream from the transcriptional start site. This part of the gamma promoter appears to function as a stage selector element and the protein with which it interacts may have a critical role in developmental switching. A mutation at -202 associated with an increase in HbF in adult life creates a binding site for this protein. Butyrates induces fetal hemoglobin synthesis in adult erythroid cells. We have localized the promoter sequences required for butyrate inducibility to the to -70 to -120 segment; these sequences bind CDP-1, a potential repressor that disappears with butyrate induction.